Molecular Dynamics Investigation of the Reactivity of Alkyl Radicals in Transition Metal-Catalyzed Transformations

Project Summary/Abstract
Computations reveal valuable information about organic reactions including those catalyzed by transition
metals. Organic chemists can map out potential energy surfaces using density functional theory (DFT) and gain
insight into the mechanism of a transformation. Using transition state theory, the reactivity and selectivity of a
reaction can be explained by these studies. However, reactions with selectivity that cannot be explained by
energy calculations performed with DFT may require the use of quasi-classical molecular dynamics simulations.
One transformation where this type of modeling is vital is in the Michael addition and nickel cross-couplings
using Watson's pyridinium salts. Despite the best experimental efforts, the Michael addition forms many
byproducts in addition to product and the nickel cross-coupling gives only byproduct. The aim of this project is
to study the dynamic behavior of alkyl radicals from a series of pyridinium salts and use this knowledge to enable
reaction design. While the barrier computed by DFT for the alkyl radical to undergo Michael addition is lower in
energy than recombination with the pyridine, a greater amount of byproduct is observed experimentally. This
lack of agreement between DFT calculations and experiments points to a need for modeling of dynamic effects.
I propose that the generation of the alkyl radical via C–N bond breaking of the pyridinium salt is an ambimodal
transition state, which does not follow the intrinsic reaction coordinate (IRC) pathway to the alkyl radical but
rather recombines with the pyridine, forming byproduct instead of the statistically favored product. I propose that
the nature of the pyridine substitution pattern will affect the distribution of products, with more electron-withdrawn
pyridines favoring radical addition. After verifying that more electron-rich, sterically hindered pyridines will favor
productive reaction, the escape of the alkyl radical from the solvent cage will be modeled. A detailed
understanding of the lifetime of the alkyl radical in solvents of varying polarity is needed, with the hypothesis
being that more polar solvent leads to a more stable radical which is more likely to undergo further chemistry.
This study is accessible solely through molecular dynamics simulations, an underexplored area that is vital to
reaction design in systems with ambimodal transition states. Using the training and information gained in this
study, in the R00 phase, I will develop chemistry to expand on existing methods of three-component coupling
processes of C-aryl glycosides in which molecular complexity can rapidly be generated from a simple scaffold.
These methods are vital to future drug design with the goal of lowering drug cost by simplifying the synthetic
pathway to access certain drugs as well as using earth-abundant metals like nickel and iron in the R00 phase.

Public health relevance
Project Narrative This research will focus on studying the dynamic behavior of the alkyl radical generated via CN bond breaking of a pyridinium salt and using this information to develop new nickel-catalyzed transformations utilizing alkyl radicals in three-component reactions. Multicomponent reactions can rapidly build a complex molecular scaffold with applications in optimizing organic syntheses for drug discovery. The streamlining of organic syntheses from multistep processes to shorter, nickel-catalyzed reactions will lead to lower drug cost and an increase in the accessibility of these compounds for the public.